Tissue engineered organ-specific cancer metastasis model for cancer research

Understanding the biology of cancer metastases is critical to improving the treatment of cancer. A key challenge
in these efforts has been the lack of cancer models that can recapitulate metastasis biology, especially organ-
specificity, a hallmark of cancer metastasis. Therefore, there is an urgent need for the development of novel
models of cancer metastasis that can reflect organ specificity of tumor metastasis. Our group has been applying
tissue engineering technologies to develop in vitro engineered cancer metastasis model. We hypothesized that
decellularized tissue can recapitulate the organ microenvironment of cancer metastasis and can be utilized as
strata for culturing tumor cells. We used an innovative decellularization technology, where the process retains
soluble extracellular proteins in the organs (decellularized tissue are termed biomatrix), to engineer cancer
metastasis. Using multiple cancer cell lines, we found that tumor cells can spontaneously form colonies on
biomatrices that are common sites of metastasis (“good soil”/liver and lung). Importantly, the biology of these
tumor colonies and treatment response reflect organ-specificity. We were also able to culture circulating tumor
cells from patients using liver and lung biomatrices. Excitingly, we also found that tumor cells were unable to
proliferate on “bad soil” biomatrices. Further study also revealed that the soluble matrix proteins are largely
responsible for the lack of proliferation of tumor cells on these biomatrices. Based on our preliminary data, we
hypothesize that we can develop an in vitro cancer metastasis model system using biomatrices and this model
system can reflect organ-specificity. We further theorize that our proposed model of cancer metastasis
represents a powerful tool for cancer biology research and hold high potential for precision oncology. In this
application, we aim to further develop and validate our metastasis model. We plan to use kidney cancer as a
disease model. Kidney cancer was chosen because its unique metastatic pattern: it can metastasize to organs
that are rarely sites of metastasis, such as pancreas. Our proposal has 3 specific aims. The first aim will generate
a comprehensive panel of biomatrices to model sites of cancer metastasis. We will conduct validation studies to
confirm the model system can recapitulate organ-specificity. Second aim will focus on demonstrating the
biomatrix metastasis model’s ability to improve precision oncology. Last aim will focus on identifying soluble
matrix proteins that prevent metastasis formation. Success with our research will result in powerful new tools for
cancer research.

Public health relevance
Our application aims to apply advances in tissue engineering to address the need for the development of cancer metastasis model that can reflect in vivo biology. We aim to engineer a novel cancer metastasis model that can reflect organ-specificity and validate this model using kidney cancer. Success of this application will provide a powerful new tool for cancer research and reveal new cancer biology.